Non-Invasive Technology (NIT) Core F

SUMMARY/ABSTRACT: Non-Invasive Technology Core F
The Non-Invasive Technology (NIT) Core supports the goals and objectives of the Precision Aging
Network (PAN) by leading the implementation and advancement of cutting edge non-invasive approaches to
capture mobility (e.g., step counts, sleep, sedentary behavior, cardiac response, and physical frailty
phenotypes), speech (e.g., prosodic and lexical features), and sweat biochemical signatures that can enhance
the early assessment of the gap between cognitive healthspan and human lifespan. The aims of the NIT Core
are to collect (1) mobility information (mobility performance and motor capacity) via both web-based data
collection modules and wearable devices, (2) spontaneous speech information via computer-based audio
recording, and (3) sweat based biosignatures via glass beads which PAN participants will roll in the palm of
their hands. The NIT Core will process and curate the data for use in conjunction with the objectives of each of
the four projects. The NIT Core will help position the PAN to implement innovative non-invasive technologies to
predict individualized aging trajectories with respect to social, physiological, behavioral and molecular
dimensions.